Single stage surgical intervention for treatment of severe traumatic brain injury

PROJECT SUMMARY
The long-term objective of this application is to revolutionize the treatment of severe traumatic brain injury (TBI)
by employing a novel osteogenic hydrogel material in an unprecedented single-stage decompressive
craniectomy (DC) procedure. DC is a common life-saving neurosurgical procedure performed on TBI patients
with either closed head injury and/or stroke. Removing the cranial bone mitigates rising intracranial pressures
by allowing the brain to swell outside the closed calvarial vault. Following the procedure, patients are currently
left with a large cranial defect (i.e., a large hole in their skull) for weeks or months and require a 2nd surgery to
replace the missing cranial bone with their preserved cranial bone or a custom 3D-printed material. In such
cases, this 2nd surgical procedure is currently unavoidable. Our strategy is unique and unprecedented by treating
TBI patients with a single-stage surgical procedure.
The key to our approach is a new class of hydrogel materials, where natural materials of demineralized bone
matrix, devitalized cartilage, or devitalized tendon are themselves the crosslinkers of the hydrogel. Our material
consists of a paste-like precursor solution of tissue particles and hyaluronic acid that behaves as a paste that a
surgeon can easily sculpt into the open calvarial defect area. With only 2 minutes of UV light exposure the
particles are crosslinked with the hyaluronic acid to create a new material that is solid, yet flexible, and can allow
the brain to swell initially, and then transition into bone as the brain swelling subsides. The innovation of this
material after crosslinking is that it can provide localized relief of swelling by releasing anti-inflammatory
molecules to improve and accelerate neurological recovery, and moreover provide a protective layer between
the scalp and the body’s most indispensable organ. The chief hypothesis is that our flexible, drug-eluting hydrogel
implants placed immediately following TBI and DC in rats will transition to complete bone spanning the cranial
defect and mitigate neurologic deficits associated with TBI. To test this hypothesis, the following Specific Aims
are proposed: 1) Tune hydrogel stiffness and bone regeneration for application to TBI, and 2) Evaluate localized
anti-inflammatory drug delivery after TBI to reduce edema/brain injury volume and thereby to improve behavioral
recovery.
Our approach is unique in that we are leveraging musculoskeletal regenerative medicine as a tool to usher
in a new paradigm for severe TBI treatment. While a primary debate in the neurosurgery field for treatment of
TBI revolves around the amount of time between the 1st (DC) and 2nd (cranioplasty) procedures, we challenge
whether that debate is even necessary. Instead, we ask whether the 2nd surgery can be eliminated altogether by
introducing a dynamic material as part of the first, and only procedure. In so doing, we hold the potential to
mitigate neurologic deficits associated with severe TBI with an unprecedented single-stage procedure.

Public health relevance
Narrative When someone suffers a severe brain injury, a portion of the skull must be removed so that the brain can swell. Unfortunately, a second surgery is required to replace that missing piece of the skull, and the patient can experience neurological problems up until the day that missing bone is replaced. In a rat model, we believe that placing our new flexible material during the first surgery that can later turn into bone will still allow the brain to swell initially, while avoiding the second surgery and the neurological problems.